Indiana Collaborative for Undiagnosed Rare Disease

Project Summary/Abstract
Undiagnosed and rare diseases affect approximately 30 million people in the United States. Those affected
often undergo a prolonged diagnostic odyssey which places a significant financial and psychological burden on
patients and families. These odysseys can be shortened by enabling access to diagnostic technologies which
can leverage insights from genomic medicine to make progress towards an eventual diagnosis. While it is
known that many underserved communities lack proper access to certain healthcare services, there is a lack of
understanding regarding how these communities lack access to specialty care, such as genetic medicine. To
date, there has yet to be a full accounting of how various spatial and non-spatial barriers impact an
underserved community’s access to rare disease-related healthcare. The Indiana Collaborative for
Undiagnosed Disease (ICUD), funded by the NINDS, seeks to improve care for individuals with undiagnosed
and rare diseases residing in Indiana and has established community partnerships with healthcare
organizations that provide care to underserved communities. The aims of these partnerships are to establish
the capacity to provide rare disease-related healthcare to these communities. The ICUD, then, provides an
opportunity to understand the various barriers that underserved communities face when attempting to access
rare disease-related healthcare. For this project, 30 individuals from underserved communities who have a rare
disease will complete a survey and interview pertaining to the spatial and non-spatial barriers that prevent
them from accessing care. Additionally, 30 clinicians who primarily serve underserved communities will
complete a survey and interview pertaining to the educational, administrative, and resource barriers that
prevent them from addressing rare diseases within their practice. These 30 patients and 30 clinicians will be
recruited from the ICUB community partnerships. The goal of this project is to produce an account of the
various social, cultural, educational, environmental, and resource barriers that prevent certain communities
from accessing diagnostic technologies and genetic medicine. This project will accomplish 3 aims. First, it will
identify barriers of access that prevent certain communities from obtaining genetics-related healthcare. Second
it will qualitatively assess how certain barriers compound with one another to create multifactorial or complex
issues of access. Finally, it will assess patient and clinician attitudes towards and challenges with modalities
that aim to improve access to healthcare. These aims make progress in NINDS mission of reducing the burden
of neurological diseases for all people; by understanding the barriers that prevent a community’s access to
diagnostic technologies that identify rare diseases, policymakers are better able to work towards solutions that
address or alleviate the impact of these barriers.

Public health relevance
NARRATIVE Undiagnosed rare disease negatively impacts patient quality of life, causes disproportionate health care utilization, and creates a tremendous economic burden for the patient and the health care system. Genomic medicine carries the promise of improving diagnosis, care, and therapeutics for individuals with rare disease but limited access to genomic medicine carries a risk of health inequity. This project proposes to improve the identification, care and diagnostic modalities for patients with rare disease.